Impact of locus coeruleus-derived tau pathology in a rodent model of early Alzheimer's disease

Amyloid-β (Aβ) plaques and tau neurofibrillary tangles, as well as neuronal death, are the pathologic hallmarks
of Alzheimer's disease (AD). Therapeutic efforts focused on Aβ have thus far failed, underscoring the urgent
need for alternate approaches, particularly those that can target early AD. Aberrant tau in the locus coeruleus
(LC), the major noradrenergic nucleus in the brain that regulates attention, arousal, stress responses, and
cognition, is the earliest detectable AD-like neuropathology in the human brain, and LC degeneration is
ubiquitious in later AD. Recent research indicates that early LC dysfunction may contribute to prodromal AD
symptoms such as depression, anxiety, and sleep disorders, while later LC degeneration exacerbates cognitive
impairment. Although these data suggest that the LC is a promising therapeutic target in AD, almost nothing
known about how pathogenic tau impacts LC function and survival. We have developed a viral vector that
drives the expression of wild-type human tau exclusively in LC neurons, which over time becomes
hyperphosphorylated and misfolded, thus recapitulating the earliest forms of human AD. We will use this novel
tool to study the consequences tau pathology in the LC. In Aim 1, we will determine the impact of different
forms of aberrant tau on LC neuron morphology, survival, and local inflammation, and assess the potential of
LC-derived tau pathology to spread to interconnected forebrain regions. In Aim 2, we will use in vivo
electrophysiology and behavioral paradigms to evaluate how tau pathology affects LC activity and performance
in neuropsychiatric and cognitive domains. In Aim 3, we will combine optogenetics and fMRI to determine how
aberrant tau influences LC-forebrain functional connectivity. Completion of these aims will lay the groundwork
for LC/tau-based therapies for early AD.

Public health relevance
Alzheimer disease (AD), a neurodegenerative disease that is the most common cause for dementia in the elderly, is characterized by a decline in mental faculties that interfere with everyday functions. AD has a crippling effect on a patient's quality of life and poses immense burdens on patients, loved ones, caretakers, and the health care system. The goal of this research is to identify new treatment strategies.